Racism's Effect on Attention Bias to Threat: Testing a Brief Mindfulness Intervention for Black Americans

PROJECT SUMMARY/ABSTRACT
Race-related stress is a public health problem and known predictor of severe psychological symptoms in Black
Americans. While there is a strong link between race-related stress and adverse mental health outcomes, little
is known about the transdiagnostic mechanisms that explain how experiencing race-related stress can lead to
psychological symptoms and what interventions may target these mechanisms. Our scientific premise is that
race-related stress can lead to disproportionately allocating one’s attention to threatening stimuli (i.e., attention
bias to threat), a known predictor of stress-related symptoms, and that this attention bias to threat can be
modified by a brief, culturally-informed mindfulness intervention. We also posit that racial identity is a key
individual difference factor that can shape the degree to which race-related stress influences attention bias to
threat and the degree to which a mindfulness intervention mitigates these biases. We will recruit 200 Black adults
from the community who have experienced race-related stress to complete a lab study to target three specific
aims, which are to: 1) Use eye-tracking methods to examine if race-related stress (vs. non-race related stress)
leads to greater attention bias to threat, 2) Test if a brief mindfulness meditation (vs. neutral audio) reduces
attention bias to threat, and 3) Investigate if racial identity influences a) the effect of the race-related stress
manipulation on attention bias to threat and b) the efficacy of the mindfulness manipulation on attention bias to
threat. In addition, this project has a strong undergraduate training component designed to stimulate
undergraduate students’ interest in research and provide both hands-on experiences and comprehensive
mentorship needed for a successful research career.
Overall, this project fills gaps in the literature by investigating how race-related stress affects threat-related
attentional processes, whether such processes can be changed via a mindfulness intervention, and for whom
such an intervention is most efficacious. We do so using a novel manipulation of race-related stress, identification
of an objective psychological mechanism, reliable and precise assessment of attention bias using eye-tracking
methods, and experimental manipulation of mindfulness, thus, addressing current limitations in this research
area. Findings from this project will advance research on understanding and overcoming the pernicious
psychological consequences of racism. Developing nuanced understandings of how race-related stress affects
mental health and how it can be treated are vital steps in eliminating mental health disparities among historically
marginalized and underserved communities.

Public health relevance
PROJECT NARRATIVE Black Americans experience significant mental health consequences due to race-related stress; yet, little is known about the psychological mechanisms through which race-related stress leads to negative outcomes and whether such mechanisms can be altered using brief, culturally-informed mindfulness interventions. To address this, we aim to investigate (a) if attention bias to threat – a novel, understudied transdiagnostic factor that reflects when one’s attention is disproportionately allocated to threatening stimuli – is such a mechanism in the race- related stress-mental health link, (b) if a brief, culturally-responsive mindfulness intervention can reduce attention bias to threat, and (c) if racial identity, a key individual difference factor, exacerbates race-related stress’s effects and amplifies the benefits of a culturally-informed intervention. To carry out this project, rigorous experimental designs and innovative eye-tracking methods in a Black community sample will be used, and findings from this project can inform the development of culturally anchored etiological and treatment models for this population.